Studying the role of TERRA in telomere protection and length regulation

PROJECT SUMMARY
Telomeres are specialized DNA-protein complex that protect the ends of linear chromosomes. Mammalian
telomeres are composed of highly conserved tandem repeat sequences of duplexed (TTAGGG)n, ending with a
3’ single stranded (TTAGGG)n sequence that is bound to telomere specific proteins known as the shelterin
complex. In healthy somatic cells, progressive loss of telomeres results in cellular senescence. In 85% of cancer
cells, however telomeres are elongated by telomerase, while the remaining 15% of cancers use alternative
lengthening of telomeres (ALT). ALT pathway leads to overexpression of Telomeric repeat containing RNA
(TERRA), a long noncoding RNA that is transcribed from telomeres. TERRA is capable of trans annealing by
invading the telomeric duplex to form an R-loop (DNA-RNA hybrid) structure. Consistently, the accumulation of
R-loops is one of the hallmarks of ALT cancer. In addition, a recent study showed that R-loop formation is
promoted by Rad51 recombinase, but it is antagonized by RNase H1. Despite the mounting evidence of
TERRA’s critical role in telomere structure and function, our molecular understanding of TERRA is limited. Here,
I propose to elucidate the molecular mechanism underlying TERRA recruitment and invasion into telomeres in
the context of shelterin proteins and the extent to which TERRA regulates telomere length in cells. Aim 1 will
probe TERRA-induced R-loop formation and the role of shelterin proteins. My preliminary results using single
molecule (sm) FRET show that TERRA trans anneals to telomeric DNA, and unexpectedly, the resulting R-loop
exhibits dynamic movement that is stabilized by TRF2. I also employed an sm-colocalization assay to measure
the efficiency for trans annealing of TERRA to telomeric DNA. My results from this assay show that the presence
of non-TERRA sequence, which represents the subtelomeric DNA, as well as the presence of G-quadruplex
(G4) telomeric overhang significantly enhances TERRA binding to telomeric duplex. Aim 2 will elucidate the
mechanism underlying TERRA recruitment and invasion by Rad51 and shelterin proteins. I present my
preliminary results using an sm-colocalization assay which show that RAD51-TERRA complex invades telomere
duplex more efficiently than TERRA alone. Aim 3 will measure telomere length as a function of TERRA levels in
ALT- and telomerase dependent cancer cells. Additionally, this aim will study the role of TRF2, POT1, Rad51,
RNaseH1 in TERRA regulation of telomeres in cells. Completion of these aims will provide a molecular
mechanism underpinning TERRA function in telomere protection and length regulation and thereby help develop
treatment for ALT positive cancers in which TERRA is upregulated.

Public health relevance
PROJECT NARRATIVE Alternative lengthening of telomeres (ALT) is a non-telomerase dependent pathway responsible for 15% of all cancers. Recent studies identified Telomeric repeat-containing RNA (TERRA), a transcript of telomere as a hallmark of ALT. This proposal aims to elucidate the molecular mechanisms underlying TERRA mediated activity and cellular function, which could help to pave a new path for treatment of ALT based cancers.